Translational and Clinical Trial Correlates Core

PROJECT SUMMARY
The goal of the Translational & Clinical Correlates Core (TCCC) is to provide the expertise and resources needed
to conduct quality correlative analyses for the research projects and clinical studies proposed as part of our
ROBIN Program. To accomplish this, we have assembled a multidisciplinary team with expertise in tissue
procurement and biobanking, immune assays, immunogenomics, proteomics, radiomics, and state-of-the-art
computational biology and biostatistics approaches. In Aim 1, the TCCC will provide highly standardized and
validated procedures to procure, process and biobank specimens. This will ensure availability of well-catalogued
and clinically annotated samples with optimal cell viability. In Aim 2, the TCCC will facilitate access to state-of-
the-art platforms for the comprehensive molecular, pathologic, and immunologic profiling of collected
biospecimens. This will provide a broad molecular assessment of the changes that occur in response to
treatment and their contributions to response. In Aim 3, the TCCC will provide access to cutting-edge
computational resources for the processing, analysis and interpretation of high-throughput data. Advanced
bioinformatics will be provided by the Center for Immunotherapy and Precision Immuno-Oncology’s
Computational Immunology Platform, and the Department of Quantitative Health Sciences (QHS) will assist with
the statistical analyses. To facilitate harmonization of data management and analysis each participating institute
will have a designated Data Resource Manager (Kattan for CC/Switchenko for Emory). This centralized
approach will ensure optimal data collection, analysis, and sharing among projects and clinical studies.